All of Us Wisconsin

All of Us-Wisconsin (AoU-W) is a consortium of Healthcare Provider Organizations (HPOs) administered by
CTSA-funded scientists from Marshfield Clinic (MC), University of Wisconsin (UW), Medical College of Wisconsin
(MCW), and Blood Center of Wisconsin (BCW). We have partnered with five FQHCs, associated with our research
institutions, with more FQHC partnerships planned for the future (years 2-5). Our HPOs (Marshfield Clinic Health
System, UW Health (UWH), Froedtert Health and Children’s Hospital of Wisconsin (CHW)), along with their
networks of hospitals and clinics, cover the majority of healthcare in Wisconsin and include substantial diversity in
terms of race and ethnic origin, socio-economic status, and rural and urban residents (Figure1). Our efforts are
focused on Federally Qualified Health Centers (FQHCs) and underrepresented in biomedical research (UBR)
participants. Much of our technical approach has recently been presented to the NIH as JIT documents (Appendix
2c). Below, we briefly summarize these plans with added detail based on new information and modifications, since we
joined the AoU program on August 26, 2017.